Auditory Effects of Sleep Apnea and CPAP Therapy

The long-term objective of this research program is to develop effective, precision-care models to improve
the functional outcomes of Veterans whose hearing difficulties are not explained by traditional hearing
loss. Determining the cause of these types of auditory processing deficits and selecting effective
rehabilitation options poses a substantial challenge for clinicians. The present proposal aims to address
whether auditory processing is affected by the presence and severity of another condition common
among Veterans and wider the American populace: obstructive sleep apnea (OSA). The objectives of
this proposal are to a). explore associations between peripheral and central auditory system function and
indices of OSA severity in Veterans with normal hearing sensitivity, and b). to provide data necessary for
the design of a full-scale Merit Award proposal addressing the utility of continuous positive airway
pressure (CPAP) therapy to improve auditory function. The central hypothesis of the current proposal is
that OSA is associated with measurable auditory processing deficits even when standard audiometric
test results are within normal limits. During the course of the study, the central hypothesis will be tested
in addition to gathering pilot data needed to inform a largescale study of CPAP therapy and auditory
function by pursuing the three specific aims, including 1) Measure the strength of the relationship between
AHI score and objective markers of central and peripheral auditory system function in Veterans with
untreated sleep apnea, 2) Develop a predictive model of auditory functional capacity based upon AHI
scores, and 3) Measure change in auditory function among patients prescribed CPAP therapies as a
function of compliance with clinically recommended CPAP usage. We will identify and recruit Veterans
who have recently been diagnosed with OSA via polysomnography (PSG) conducted at the Portland VA
Medical Center (n = 45), as well as a group of healthy control Veterans of similar age (n = 10). Recruited
patients will have a range of OSA severity based upon Apnea-Hypoxia Index (AHI) including mild,
moderate and severe. Exclusionary factors include cardiovascular & cerebrovascular disease, diabetes,
age greater than 55 years, and clinical hearing loss. All participants will complete a rigorous audiometric
test battery including behavioral measures of auditory processing, physiological measures of cochlear,
brainstem, and cortical responses to sound, and self-report measures of hearing handicap and function.
The strength of relationships between these auditory functions and measures obtained via PSG will then
be examines, including the AHI, oxygen desaturation index, hypercapnia load, and snoring amplitude.
This data will be used to develop a model predicting auditory function based upon AHI score. Finally,
OSA patient participants will repeat all auditory testing following two months of CPAP therapy. Changes
in auditory capacity will then be assessed as a function of compliance with CPAP usage. This information
will provide pilot data regarding the influence of CPAP therapy on auditory function and will allow us to
gather data necessary for the planning and implementation of a future clinical trial including recruitment,
retention, screen failures, and compliance with recommended therapy. This work will advance clinical
care for Veterans with hearing difficulties unrelated to hearing loss by identifying a potential contributing
source underlying dysfunction leading to improved diagnostic test batteries and counseling. In addition,
this work will lay the foundation for performing a subsequent study aimed at determining whether CPAP
therapy can improve auditory function and possibly even prevent or mitigate development of permanent
hearing loss and tinnitus associated with longstanding OSA.

Public health relevance
At least 10% of Veterans seeking help for auditory difficulties in VA Audiology clinics are found to have normal hearing sensitivity. Identifying the cause of auditory processing problems in these Veterans and determining effective rehabilitation strategies is a significant challenge for clinicians. A survey of VA Electronic Medical Records data found that approximately 20% of the Veteran population had a diagnosis of obstructive sleep apnea (OSA) in 2021. OSA is associated with several health conditions including cognitive deficits, cardiovascular disease and an increased likelihood of hearing loss and tinnitus. If OSA is associated with auditory functional difficulties, these deficits are likely to present before the onset of permanent hearing loss. Early identification of auditory difficulties associated with OSA may provide a novel route for improved auditory function via continuous positive airway pressure (CPAP) therapy, one which may also help to mitigate or prevent future development of permanent hearing impairment.